Evaluation of Streptamine Analogs to Overcome Resistance to Apramycin

Aminoglycoside antibiotics (AGAs) are potent antibiotics which have long been used as
potent broad-spectrum antibiotics, with targets including Gram-negative and Gram-positive
pathogens, and complex infectious diseases such as hospitalized CAPD and exacerbated CF.
Apramycin is a novel aminoglycoside antibiotic that retains all of the typical advantages
of the aminoglycosides but, because of its unusual structure, offers the additional benefits of
avoidance of the vast majority of aminoglycoside resistance determinants and of reduced oto-
and nephrotoxicity. As such apramycin is currently in clinical trials in Europe and in the USA for
the treatment of multidrug-resistant Gram-negative infections.
A major advantage of apramycin is its lack of susceptibility to activity-damaging
alteration by aminoglycoside modifying enzymes, with the single exception of the
aminoacetyltransferase isozyme AAC(3)-IV, which portends well for its use against carbapenem-
resistant Gram-negative infections. Nevertheless, resistance due to the acquisition of the
AAC(3)-IV gene will eventually inevitably emerge. The goal of this proposal is to test the novel
hypothesis that advanced apramycin analogs (apralogs) can be designed and easily prepared
that circumvent the AAC(3)-IV resistance determinant through the introduction of a simple
hydroxy or alkoxy group at the 2-position on the deoxystreptamine core of apramycin, ie, based
on the streptamine core.
To test this novel hypothesis a series of some forty advanced apralogs will be prepared
based on the streptamine core and screened, in an iterative feedback loop, for antibacterial
activity in the presence of AAC(3)-IV and other resistance mechanisms. Compounds will also be
screened for activity at the target level using cell-free translation assays with bacterial
ribosomes and for selectivity over eukaryotic ribosomes using comparable cell-free translation
assays with mutant bacterial ribosomes carrying human decoding A sites. These later studies
will provide a measure of selectivity and are predictive of toxicity, thereby ensuring that the
excellent toxicity profile of the parent apramycin is retained in the new analogs.
At the end of the study, the goal is to have a small set of advanced compounds that are
not susceptible to the AAC(3)-IV mechanism of resistance, and retain the otherwise excellent
broad spectrum activity and minimal toxicity of the parent apramycin.

Public health relevance
Apramycin is an unusual aminoglycoside antibiotic with minimal oto- and nephrotoxicity and minimal susceptibility to common mechanisms of aminoglycoside resistance. As such it is currently in clinical trials in Europe and the USA under development for the treatment of multidrug-resistant bacterial infections. Nevertheless, resistance to apramycin is expected to eventually surface because of its susceptibility to a single isoform of an aminoglycoside modifying enzyme, the aminoacetyltransferase AAC(3)-IV. This proposal, through a combination of design, chemical synthesis, and antibacterial and antiribosomal screening, test the hypothesis that improved analogs of apramycin based on the streptamine core (as opposed to the existing 2-deoxystreptamine core) can be designed and prepared that overcome the inherent susceptibility to AAC(3)-IV without loss of the broad-spectrum activity or minimal toxicity of the parent.